PHARMACIST-INTEGRATED MODEL OF MEDICATION TREATMENT FOR OPIOID USE DISORDER (CTN-0116). 09/01/2021 - 03/01/2024. N01DA-19-2250. TASK ORDER 75N95021F00

PHARMACIST-INTEGRATED MODEL OF MEDICATION TREATMENT FOR OPIOID USE DISORDER (CTN-0116).